Lipidation and Vascular Disease

Project Summary/Abstract
Peripheral artery disease, more prevalent than coronary heart disease or stroke, is often ignored. The
disease is increasing with the aging of the population and the epidemic of diabetes, but therapeutic options are
limited. Unlike coronary heart disease, peripheral artery disease is not consistently associated with risk factors
such as lipoproteins and hypertension, and it appears to be more prevalent and more clinically aggressive in
women as compared to men.
Chronic vessel immaturity characterizes peripheral artery disease. Fatty acid metabolism impacts
remodeling of the vasculature, and the fatty acid palmitate has pleiotropic functions that include protein
lipidation. Successive cycles of palmitoylation followed by depalmitoylation are critical for membrane trafficking.
We generated a mouse with deficient endothelial acyl-protein thioesterase 1 (APT1), the dominant enzyme for
reversing protein palmitoylation. This animal is a model for human peripheral artery disease. Palmitoylated R-
Ras, caused by APT1 deficiency, accumulates in the vasculature of these animals, and expression of an R-
Ras molecule engineered to restore intracellular trafficking rescues physiologic defects. Decreased APT1
enzyme activity and increased palmitoylated R-Ras are found in diabetes models.
Lower extremity arteries from humans with diabetes and peripheral artery disease have a significantly
greater content of palmitoylated R-Ras (reflecting impaired APT1 activity) compared to arteries from control
nondiabetic humans with no vascular disease. APT1 appears to have a disproportionate effect in female as
compared to male mice, and vascular tissue from human females with peripheral artery disease has
significantly greater content of palmitoylated R-Ras (reflecting decreased APT1 activity) as compared to
vessels from human males with peripheral artery disease. To pursue these observations, we will test the
hypothesis that deficiency of the depalmitoylation enzyme acyl-protein thioesterase 1 (APT1) promotes
peripheral artery disease. Our specific aims are: 1) To determine if increasing APT1 enzyme activity by
pharmacologic and genetic approaches decreases peripheral artery disease in mice. 2) To determine if sex
specific effects on APT1 enzyme activity and its downstream target R-Ras contribute to increased peripheral
artery disease in mice. 3) To translate this work to humans by determining if the consequences of decreased
APT1 enzyme activity, the accumulation of palmitoylated R-Ras and altered fibronectin processing, are
reflected in arteries from women and men with peripheral artery disease.
Achieving these aims has the potential to identify a novel target for a neglected disease, and to provide
insight into how sex and diabetes affect peripheral artery disease.

Public health relevance
Project Narrative Peripheral artery disease, atherosclerotic occlusive disease of the lower extremities, occurs in nearly a quarter of a billion people, disproportionately affects women and individuals with diabetes, and commonly leads to amputations. Current therapies are inadequate. This application is relevant to public health because it has the potential to discover new approaches to decrease the burden of peripheral artery disease in the United States.